Using DNA Repair and Damage as a Tool in Personalizing Aging and Aging Related Diseases

This project aims to use DNA repair and damage as a tool to personalize aging and aging-related diseases,
with a particular focus on US veterans who are at increased risk for lung diseases such as COPD and lung
cancer. The global population, including our veterans, is aging rapidly, with the percentage of people aged 60
and over projected to equal that of those younger than 15 by 2050.
Aging is characterized by a range of characteristic DNA alterations, including decreasing telomere length,
epigenetic alterations, and genomic instability, which are considered hallmarks of aging. Decreased expression
of DNA repair genes through epigenetic regulation is implicated in the development of lung, breast, and other
cancers of advancing age, providing a plausible mechanism by which accumulated DNA damage leads to
genomic instability. Additionally, decreased DNA repair has been linked to accelerated COPD in an early aging
pattern.
Through our previous work, we have optimized a host cell reactivation-coupled flow-cytometry assay to
measure titratable levels of DNA repair capacity (DRC) for two repair pathways, Nucleotide Excision Repair
(NER) and Non-Homologous End Joining (NHEJ), in human cryopreserved peripheral blood mononuclear cells
(PBMCs). The research hypothesis is that individual DRC measured in human PBMCs is decreased with age
and further decreased in those with aging diseases including lung cancer and COPD and can be modified by
lifestyle modifications.
The study will measure NER and NHEJ DRC in cryopreserved PBMCs as well as DNA damage collected from
young subjects, as well as those with and without age-related lung diseases, to determine if DRC can serve as
a personalizing biomarker of premature biological aging. The study will also investigate whether specific
lifestyle interventions, particularly in a high-risk population, can help improve DNA repair and decrease DNA
damage as a step towards modifying aging processes and its related diseases.
The project's outcomes are expected to identify the interaction between DRC and biologic vs. physiologic
aging, as well as interrogate the mechanistic impact. The project will also determine the impact of specific DNA
repair/damage processes on the risk of developing lung cancer and COPD, as well as how individual PBMC
DRC is affected by modifiable lifestyle factors. The results of this study will have a strong impact on
understanding the aging process and aging-related diseases. Additionally, it can help identify those at
increased risk for such diseases, allowing for personalized, targeted interventions, including lifestyle
modification or early, disease-specific screening

Public health relevance
DNA repair is a critical process that maintains genetic stability in cells. However, as we age, our cells become less efficient at repairing DNA damage, resulting in the accumulation of genetic damage over time. This accumulation can contribute to the development of age-related lung diseases, such as cancer and COPD, which are more prevalent in veterans who are rapidly aging. Our hypothesis is that individual DNA repair capacity (DRC), measured in human peripheral mononuclear cells (PBMCs), decreases with age and further declines in individuals with age-related lung diseases, including lung cancer and COPD. Our goal is to compare DRC, DNA damage, and epigenetic markers between younger and older subjects with and without lung diseases, and to investigate the impact of modifiable lifestyle factors. The findings from this study will significantly impact our understanding of the aging process and related diseases, and will help identify individuals at increased risk for such diseases who may benefit from targeted interventions.